HIV innate sensing in glial cells and inflammation

Project Summary
Even in the era of combination antiretroviral therapy (cART), people living with HIV (PLWH) exhibit a broad
spectrum of neurocognitive disorders collectively termed HIV-Associated Neurocognitive Disorders (HAND).
Inflammation in the brain is a hallmark of HAND, yet the mechanisms that drive this inflammation in the cART
era are not entirely clear. cART penetration into the brain is lower than in other tissues and can also lead to
production of noninfectious particles. Under these two scenarios, viral innate sensing may be triggered in glial
cells (microglia and astrocytes) to mediate persistent inflammation. We will assess mechanisms of innate
sensing in glial cells. Based on our body of work, we hypothesize that the activation of the cGAS/STING innate
sensing pathway is strong and lasting after detection of HIV particles or virus like particles in glial cells, leading
to inflammatory cytokine production which, in turn, will result in persistent neuroinflammation. Specifically, we
will determine the impact of HIV post-entry events on innate immune sensing in glial cells (aim 1) and
determine the biologic consequence of HIV-mediated innate sensing on astrocytes, either directly or through
cross-talk with microglia (aim 2). We will use iPSC-derived microglia and astrocytes in our studies as well as
sophisticated molecular, biochemical, and imaging tools to address our overall hypotheses. Our work will
define a novel pathway that may drive and/or contribute to persistent neuroinflammation in the era of cART,
which can inform targeted strategies to ameliorate and/or reduce HIV-associated neuroinflammation.

Public health relevance
PROJECT NARRATIVE A high number of people living with HIV develop HIV associated neurocognitive disorders despite effective systemic antiretroviral therapy. The events leading to the establishment of inflammation in the brain which play a part in neurocognitive disorders are not entirly clear. We will characterize a mechanism of viral sensing in the brain that can trigger chronic inflammation, this knowledge can inform future therapy avenues.